Vasomotor symptoms of menopause and cardiovascular disease: What is the link?

Project Summary/Abstract
Aging is a risk factor for cardiovascular disease (CVD), and females who experience vasomotor symptoms (VMS,
hot flushes and night sweats) have a 55% greater risk for CVD compared with females who do not experience
VMS. Because CVD is the leading cause of mortality in females in the US, the factors contributing to CVD in
menopausal females are critical to determine and yet are unclear. Autonomic and vascular dysregulation, often
demonstrated in postmenopausal females, is associated with CVD, but whether this dysregulation exists
specifically in females with VMS is unknown. Further, how hot flushes, a major VMS, alter autonomic function
has not been well defined. This application for a NIH R21 is designed to identify mechanistic pathways to
determine how VMS lead to CVD. Dr. Manda L Keller-Ross, DPT, PhD, an Assistant Professor in the Department
of Rehabilitation Medicine, in the Medical School at the University of Minnesota, is the PI of the Cardiovascular
Research and Rehabilitation Laboratory, where the proposed research will take place. The long-term objectives
of this proposal are to determine the link between VMS and CVD in menopausal females. Specifically, Dr. Keller-
Ross aims to determine the extent that females who experience VMS demonstrate autonomic and vascular
dysregulation (Aim 1). She will then delineate the mechanism by which hot flushes alter autonomic regulation
(Aim 2). This proposal is in line with the mission of the NIA, to understand the nature of the aging process in
females and how factors associated with menopause contribute to the number-one cause of death in females,
CVD. Dr. Keller-Ross seeks to conduct an exploratory study to interrogate the thermoregulatory system in
females by inducing hot flushes and investigating how hot flushes alter autonomic function. To accomplish
these research objectives, Dr. Keller-Ross and Dr. Blas (Co-I) will use gold-standard techniques combined
with an innovative methodological approach to quantify autonomic and vascular dysregulation in females with
VMS. Aim 1 will quantify muscle sympathetic activity (MSNA), measured via microneurography; endothelial
dysfunction, measured with Endothelial Pulse Amplitude Tonometry; vascular conductance, measured via
venous occlusion plethysmography; and baroreflex sensitivity in postmenopausal females who experience VMS.
We hypothesize that females with VMS will demonstrate elevated MSNA, reduced vascular conductance and
impaired endothelial function, leading to elevated BP, compared with females without VMS. Aim 2 will explore
the extent to which a hot flush, induced by a temperature-controlled, water-circulating heating pad, alters
autonomic function in postmenopausal females. We hypothesize that a hot flush will cause an increase in MSNA,
contributing to chronic autonomic dysregulation of BP in menopausal females. By identifying the link between
VMS and CVD, we will set the stage for the development of novel therapies and optimization of current treatments
for VMS with the goal of reducing sympathetic activity and restoring autonomic and vascular function to mitigate
CVD risk in females, particularly for those who experience VMS.

Public health relevance
Project Narrative Aging women are at an increased risk for cardiovascular disease, which is the number-one cause of death for women in the US; those who experience vasomotor symptoms (hot flushes and night sweats) have a 55% increased risk of cardiovascular disease compared with women who do not experience vasomotor symptoms. The proposed research aims to determine whether autonomic regulation and vascular control are altered in postmenopausal women with vasomotor symptoms and uses a novel and innovative approach to determine how a hot flush influences blood pressure regulation. Findings from this study will break new ground on mechanisms that link vasomotor symptoms to cardiovascular disease in these women and will further inform future research on preventive and treatment strategies to improve cardiovascular health in aging women.